Diversity Supplement: Mechanisms of striatal structural and functional plasticity

PROJECT SUMMARY Dendritic spines are the remarkable, specialized membrane compartments on neurons that house the postsynaptic, receiving end of most excitatory, glutamatergic synapses in the brain. They are highly plastic and change during development, learning, and in disease. This proposal relies on multi-laser 2-photon imaging and photostimulation approaches to generate and evaluate new connections on genetically targeted striatal neurons, dissecting interacting variables of sex, age, and neuromodulatory state. The proposal builds on preliminary observations of sex differences in spinogenesis, which may interact with other convergent signaling cascades to control dendritic spine formation and sensitivity to therapeutic agents. The proposed work would yield valuable insights into new spine and synapse genesis, early-stage function, and stability, impacting basic research relevant to synaptic development and rules that guide plasticity. The resulting platform will help to drive technical innovation that would allow researchers to design therapies to augment reconstruction of neuronal architecture or deconstruct aberrant connectivity. The current supplement introduces a new form of imaging to the project, while supporting a promising undergraduate student in research and career development.

Public health relevance
PROJECT NARRATIVE The ability of neuronal connections to grow or strengthen is a foundational property of neurons, essential for development, learning, and survival of the organism. This project uses multi-laser microscopy to create and interrogate new dendritic spines and neuronal connections on genetically targeted cell types. This administrative supplement to support an undergraduate researcher introduces a new form of custom light-sheet microscopy into the project.